Predicting Substance Use among Military Veterans with a Positive MST Screen: A Machine Learning Approach

Project Summary/Abstract
Military sexual trauma (MST) is a serious and pervasive problem among military populations, affecting
approximately 16% of military personnel and veterans [1]. Substance use disproportionately affects individuals
with a history of MST. Individuals with (vs. without) a history of MST are twice as likely to misuse substances
[2-4]. Substance use among military samples has been linked to higher rates of negative consequences across
several domains (e.g., health, occupational, legal [5, 6]), including death (e.g., overdose [7], traffic accidents
[8], suicide [7, 8]). Further, while understudied among individuals with a history of MST in particular, negative
substance use outcomes have been shown to be more severe among trauma-exposed populations, including
more severe clinical presentations and poorer treatment prognosis [9, 10]. These findings emphasize the
importance of clarifying the association between MST and substance use among military populations.
Despite the clinical relevance and public health significance of substance use among military populations,
research in this area has relied almost exclusively on cross-sectional designs. Moreover, the vast majority of
studies in this area have utilized traditional statistical methods, which are limited in scope and capabilities.
These limitations have important clinical implications, as they restrict our ability to specify the exact nature and
directionality of the relationship between MST and substance use, thereby affecting how findings are translated
into prevention and intervention efforts. The proposed research aims to fill these critical gaps by utilizing the
Army STARRS pre/post-deployment study, a large, prospective military dataset to: (1) explicate the directional
relation between MST and substance use using a longitudinal dataset, and (2) employ machine learning
methods to develop an algorithm to optimize detection of substance use in military personnel with a history of
MST. These findings will assist in elucidating the etiology of substance use among this high-risk group, as well
as provide a prediction model for clinical use to better target at-risk individuals in this population.
This research project will take place within the Department of Psychology at the University of Rhode Island; an
institution with a strong history and commitment to health behavior research and methodology. The applicant
will have access to sponsors and consultants with expertise in MST, substance use, advanced methodology,
and statistical analysis that will facilitate her career objectives to develop increased knowledge and proficiency
in (a) sexual trauma (e.g., MST) and substance use in military veterans; (b) grant/manuscript development; (c)
statistical and methodological capabilities (i.e., machine learning); and (d) big data.
The proposed project uses a timely and innovative approach to advance science on the relation between MST
and substance use in military personnel. Addressing substance use in this population is necessary to improve
the health of our nation's veterans, and aligns with the mission of the National Institute on Drug Abuse.

Public health relevance
Project Narrative Military sexual trauma (MST) is highly prevalent among military personnel and is associated with disproportionate rates of substance use. By explicating the directional relation between MST and substance use, and utilizing machine learning to develop high-quality prediction models for clinical use, the proposed study will inform prevention and intervention efforts for this high-risk group. Findings will be used to improve clinical outcomes among military personnel with exposure to MST, and reduce the onset and maintenance of problematic substance use and associated negative consequences.